Circulating urinary microRNAs as systemic biomarkers of healing outcomes in diabetic foot ulcers

Project summary
Diabetic foot ulcers (DFUs) are a widespread, serious, and common complication of diabetes. Diabetes-related
amputations are associated with disability, drastic reduction in quality of life, high morbidity and resulting
alarming mortality rate of 35% over 5 years. Non-invasive detectable biomarkers that correlate with healing
outcomes of DFU are critically needed for early targeting of hard-to-heal ulcers for advanced interventions
beyond standard of care (SOC) therapy, as well as for timely monitoring of response to treatment. Preliminary
evidence developed in our laboratory supports circulating urinary microRNAs (miRNAs) as detectable
biomarkers for DFUs and other diabetes-associated complications; these miRNAs can be isolated and
quantified from urine in a technically robust and reproducible manner. Utilizing an R61/R33 funding mechanism
in response to RFA-DK-21-001, this project will capitalize upon patient enrollment in the existing protocols and
infrastructure of the Diabetic Foot Consortium to develop a practical, quantitative, non-invasive, cost-effective
prognostic biomarker comprised of a urinary microRNA subset that, when assessed in patients at baseline,
accurately and reliably differentiates DFUs that have the capacity to heal with SOC from those that do not.
Specifically, in R61/ Exploratory phase, a combined data reduction and prognostic modeling approach will be
applied to narrow the determine miRNome of top 10-20 miRNA parameters that predict DFU clinical healing
outcomes at Week 12. Sensitivity, specificity, and accuracy of predictions will be evaluated and with
successful completion of R61 milestones the model will progress to the R33/Validation phase, in which the
custom miRNA subset biomarker panel will be interrogated for its ability to predict healing outcomes in a
prospectively enrolled cohort of 100 additional patients with open DFUs. Results of the Validation phase will
yield a biomarker ready for submission for FDA biomarker qualification approval and subsequent direct clinical
implementation as a point-of-care assessment to guide clinical management decisions and improve wound
closure outcomes, thereby reducing associated DFU morbidity and mortality.

Public health relevance
Narrative Diabetic foot ulcers (DFUs) are a devastating complication of diabetes and represent a major risk factor for amputation of the affected foot. This proposal will non-invasively measure small RNAs in the urine of patients with DFUs and study their ability to predict early which ulcers are unlikely to heal with standard DFU treatments. Results of this project will allow clinicians to promptly identify hard-to-heal DFUs that warrant early intensive therapies, increasing the likelihood of ulcer closure and minimizing pain and risks of serious complications from a chronically open wound.